Training Grant in Precision Cancer Control

PROJECT SUMMARY
In the United States, more than 40 percent of new cancer cases can be attributed to modifiable factors. Yet,
despite advances in knowledge regarding the multilevel factors associated with cancer risk, the annual number
of cancer cases is predicted to increase nearly 50%, from 1.5 million new cases in 2015 to approximately 2.3
million in 2050. Thus, a greater emphasis on cancer risk reduction and cancer control – along with a highly
trained workforce in this domain -- is needed to counter this projected increase. Recent advances in precision
medicine have resulted in great optimism for potential therapeutic options and may provide a ‘model’ for how to
evolve the field of cancer control. To realize the full potential of precision cancer control, it will be imperative to
not only assess biologic properties, but to also consider individual variabilities in behavioral, lifestyle, and
environmental factors. As a result, precision cancer control research requires multidisciplinary approaches that
enable seamless integration and collaboration to inform our understanding of how to identify those individuals
who are at elevated risk or who might benefit from specific, effective, and implementable interventions. Thus,
there is a significant need to equip the next generation of cancer control scientists with skills required to: (1)
precisely characterize the populations at increased risk for cancer or poor outcomes; (2) identify the multilevel
factors contributing to elevated risk or negative outcomes; and (3) develop and implement appropriate
interventions to effectively address those factors. This application for a new T32 postdoctoral training program
at Fox Chase Cancer Center is designed to prepare PhD and MD postdoctoral fellows to conduct innovative
research in precision cancer control with diverse populations. The transdisciplinary training includes a
complementary program of didactic activities and intensive mentored research experiences, which will equip
trainees to lead independent careers in precision cancer control. The Program Faculty include 25 mentors, all of
whom have established track records of obtaining peer-reviewed funding. We propose to enroll 2 postdoctoral
fellows each year (for two-year terms) over the five-year award. All fellows will receive rigorous training in the
principles of precision cancer control, research design and methodology, grant-writing, responsible conduct of
research, and career/professional skills development. T32 mentors are drawn from a broad base of exceptional
Cancer Center faculty with a breadth of expertise ranging from molecular biology, genetics, epidemiology,
biostatistics, geospatial technology, psychology, public health, and implementation science. The rich resources
available at Fox Chase Cancer Center (FCCC) include comprehensive genomic, biologic, sociocultural,
behavioral, and environmental-level data combined with advanced geospatial and statistical tools that will enable
our faculty and their trainees to apply precision cancer control methods in strategic efforts toward reducing cancer
risk and mortality across diverse populations.

Public health relevance
PROJECT NARRATIVE The ability to precisely target individuals with cancer and at-risk populations with evidence-based tools to address individual, sociocultural, or environmental factors is likely to lead to the greatest improvements in cancer outcomes and reductions in cancer risk. Thus, this application for a new T32 postdoctoral training program at Fox Chase Cancer Center is designed to prepare PhD and MD postdoctoral fellows to lead innovative and scientifically rigorous research in precision cancer control with diverse populations.